Role of the X-chromosome in Pulmonary Arterial Hypertension

Project Summary Pulmonary arterial hypertension (PAH) is a serious lung disease characterized by proliferative changes in the small pulmonary arteries that leads to vessel narrowing, elevated pulmonary artery pressure and right heart failure. There is growing evidence that proliferative lesions in the lungs of PAH patients are akin to neoplasia, with monoclonal expansion and genetic instability. Supporting this, we recently identified chromosomal abnormalities in endothelial cells from PAH lungs, including mosaic deletions of the X-chromosome in 16% of female cases. We have also found a surprisingly high frequency (32%) of very skewed X-inactivation patterns, which may represent monoclonality or reactivation of the inactive X-chromosome. In this study we will conduct a detailed analysis of X-inactivation in primary cell cultures and uncultured lung tissue to distinguish these two hypotheses and also identify whether cases with X-chromosome deletion have lost the active or inactive X. Allele-specific expression of X- linked genes will be analyzed using next generation sequencing and in situ hybridization will be performed to visualize X-chromosome copy number and XIST expression, a marker of X-inactivation, in uncultured tissue sections. Determining the frequency of monoclonality is critical to the neoplasia-like model for PAH pathogenesis and other abnormalities of the X-chromosome may in part explain the higher incidence in females than males.

Public health relevance
Relevance Pulmonary arterial hypertension (PAH) is a serious, potentially life-threatening lung disorder with a complex etiology. This study will use lung tissue from patients with PAH who have undergone lung transplantation to characterize changes in the X-chromosome that occur during the course of the disease. The long-term goal is to understand how PAH develops and design more effective treatments.